Development of broad nanovaccines targeting diverse coronavirus receptor-binding sites

Project Summary
The first project of our pan-CoV proposal is titled ‘Development of broad nanovaccines targeting diverse
coronavirus receptor-binding sites’. Our team’s expertise will culminate in structurally guided coronavirus
nanoparticle vaccines to broaden CoV vaccine protection. This proposal utilizes our novel platform to
develop potent, RBS-focused nanoparticle vaccines to induce broad protection across CoV lineages,
escape mutations and potential pandemic CoVs that are of concern. The project aims are: (1) Create a
library of mutants that escape coronavirus immunity (2) Develop RBS-focused nanoparticle vaccines to induce
broadly neutralizing antibodies to conserved sites using nucleic acid delivery and (3) Develop vaccine regimens
to induce broad immunity and protection across diverse CoVs.

Public health relevance
Project Narrative Ongoing SARS-CoV-2 vaccine candidates are largely focused on efficacy against a single coronavirus but lack broad protection against CoVs. In this proposal, we will identify mutations with vaccine escape and pandemic potential, design nanoparticles that focus the antibody response to the neutralizing RBS epitope, and assess vaccine regimens that induce breadth across diverse CoV lineages.